SOURI (SMILE)

PROJECT SUMMARY
Miami, Florida, is an epicenter for new HIV diagnoses in the US,1 and Haitian individuals have been
disproportionately affected.2 In the population of over 300,000 Haitian individuals living in Miami,3 Haitian
women suffer from various health disparities, including poor HIV outcomes, and have the highest HIV-related
mortality among immigrants.2,4 Haitian women face numerous barriers to care, such as language, cultural
context, financial resources, and immigration status, which worsen their health outcomes.5 We have previously
described that women living with HIV have unmet dental needs impacting oral health and oral conditions such
as periodontitis associated with HIV may be worse among women due to hormonal changes.6,7 Chronic use of
antiretroviral therapy for HIV has also been associated with decreased saliva, impairing chewing and
swallowing while increasing the risk of dental caries, and worsening quality of life.8 Oral health is essential in
one’s overall well-being, and poor oral health has been connected to mental health concerns and worsened
HIV-related outcomes, which may only be exacerbated for Haitian women.5,9,10 Unfortunately, there is limited
data regarding oral health among Haitian women, a marginalized, underserved population. Additionally, there is
a gap in understanding how social determinants of health play a role in oral health among Haitian women. We
hypothesize that barriers to accessing health care impact oral health.
This project will have the following aims:
Aim 1: Evaluate social determinants of health, mental health, and cultural factors impacting the unmet oral
health needs of Haitian women with and without HIV in Miami.
Aim 2: Adapt and pilot culturally tailored measures to evaluate oral health quality of life and mental health, and
assess oral health among Haitian women with and without HIV.

Public health relevance
PROJECT NARRATIVE This proposal is a supplement to the Comprehensive Research on Oral and Mental Health among WomeN (CROWN) study. This study seeks to understand better the connection between HIV, social determinants of health, mental health, and oral health among Haitian women. Haitian women are underrepresented, underserved, underreported, and have poor HIV-related outcomes so we would be better suited to address their needs with this information.